Controlling Robot-Assisted Locomotion with Extended Kalman Filter Estimates of Phase and Activity

PROJECT ABSTRACT This diversity supplement to the parent R01 project will address our overall goal—to model and control human locomotion over continuously varying tasks—by indirectly estimating a gait-state comprising (1) the phase variable, (2) the phase rate, and (3) a selection of task variables such as the step length and ramp inclination. The phase variable is a signal that monotonically increases during the natural progression each human stride, and the phase rate is the rate of change of the phase variable. Task variables represent the physical characteristics of a locomotion task, such as the ground’s inclination or the speed of the human. Grouped together in the gait-state, these variables parametrize human leg kinematics and kinetics through a gait- mapping, which must be learned from gait data. The central hypothesis of this project is that continuously varying activities can be tracked in real-time by using the theory of state estimation to estimate this gait-state vector indirectly through a comparison between measured human kinematics and the kinematic predictions of the gait-mapping; this estimate can then be used to either imitate (in the prosthetic case) or augment (in the orthotic case) the human’s behavior. In this research, PhD candidate Roberto Manuel Leonardo Medrano III, BS (Leo) will be advised by PI Robert Gregg, PhD and Co-I Elliott Rouse, PhD, who will help him develop as a leader/researcher throughout the course of this project at the University of Michigan (U-M).

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the clinical application of variable-activity wearable robots can significantly improve community mobility and therefore quality of life for millions of Americans with disabilities. Recently developed powered prostheses and exoskeletons are limited to a small set of pre- defined activities. This project will model and control human locomotion over continuously varying tasks for the design of agile wearable robots, which aligns with the missions of the Devices and Technology Development program area of the NICHD National Center for Medical Rehabilitation Research.